HISPANIC COMMUNITY HEALTH STUDY (STUDY OF LATINOS (HCHS-SOL) FIELD CENTER - DIVERSITY SUPPLEMENT FOR CELESTIN MISSIKPODE.

This Diversity Supplement for research and training builds upon Dr. Missikpode’s methodological background and extends into machine learning, thus laying the foundation for a successful academic career in cardiovascular disease prevention research. The research project, “Population-Based Screening Tools: Comparing Traditional versus Machine Learning Techniques? leverages existing data from the Hispanic Community Health Study/Study of Latinos (HCHS/SOL) to explore the potential of machine learning techniques for developing screening tools that can be used by lay people to assess disease likelihood and the need for further evaluation. A screening tool developed using this method can be represented graphically as an algorithm that can be easily navigated by anyone.